Chimeric Ligands for Induced Proximity (CLIP) platform for targeted proteome editing to treat severe alcoholic hepatitis

Abstract
UbiquiTx is advancing a modular platform technology called chimeric ligands for induced proximity (CLIPs) to
induce posttranslational modifications to proteins of interest that will help address the critical need for novel
therapeutics. There is a critical need to leverage novel bioactive molecules that can achieve targeted protein
modification, including addition and removal of ubiquitin to de-stabilize or stabilize proteins, respectively. It would
be particularly advantageous to apply bioactive molecules to address alcoholic hepatitis (AH), a severe form of
alcoholic liver disease that causes such severe damage to liver that the liver’s regenerative capacity is
diminished. Current treatment for AH is corticosteroids, which is not an effective or long-term option. Although
liver transplant is the most effective way to address AH, the organ donation list is long and many AH patients die
while waiting for transplant. However, nuclear erythroid 2-related factor 2 (Nrf2), a regulator of anti-inflammatory
and antioxidant gene expression, has become a therapeutic target of great interest for the treatment/prevention
of liver diseases. The dysregulation of Nrf2 is correlated with chronic liver disease, and its activation has been
shown to modulate gene expression to prevent oxidative and inflammatory disease in studies with ethanol
induced hepatotoxicity in mice. UbiquiTx’s CLIPs comprise a computationally designed target recognition domain
fused with a protein modification enzyme component of choice (e.g., ligases, kinases, deubiquitinates). This
novel platform can be used to program the localization, binding, turnover, and activation of disease-relevant
proteins currently considered “undruggable” by existing therapeutic modalities.
In this Phase I SBIR project, UbiquiTx will develop and test deubiquitinating CLIPs (dubCLIPs) with the goal of
enhancing Nrf2 activity through stabilization as a novel therapy for AH. To achieve this goal, the following aims
will be completed: 1. Identify and optimize dubCLIPs that target and stabilize Nrf2 levels through a combination
of in silico and in vitro approaches. Multiple AI/ML designed peptides will be designed and screened, then their
binding will be validated to identify, characterize and optimize lead dubCLIPs consisting of the right guide peptide,
linker, and deubiquitinase enzyme. Target binding activity (kinetics/affinity), effects on Nrf2 levels, downstream
effects on antioxidant responsive genes (ARGs), and potential off-target effects in vitro will be evaluated. The
potency, amplitude and duration of effect of the Nrf2-stabilizing dubCLIPs in cellular models of oxidative stress
will also be determined to identify the top leads to advance. 2. Demonstrate in vivo target engagement for lead
dubCLIP Nrf2 stabilizers. mRNAs encoding the lead dubCLIPs from Aim 1 will be packaged in lipid nanoparticles
and administered to healthy mice to assess the pharmacokinetic (PK) parameters of dubCLIPs, including the
stability and half-lives of the dubCLIP mRNA and protein in the target tissue and the in vivo levels of Nrf2
stabilization, downstream ARGs, and off-target effects.

Public health relevance
Narrative UbiquiTx’s Phase I work will identify a lead candidate for future evaluation of efficacy in AH animal models in Phase II, as well as additional PK/PD and safety/toxicity studies to advance the lead candidate; the proposed research will also help advance the commercialization of UbiquiTx’s proprietary therapeutics toward an IND and initial clinical evaluation. In the long term, UbiquiTx’s work constitutes a new paradigm for drugging the proteome based on computational design of peptide-guided CLIPs and enhances the translation of novel therapies for multiple indications to the clinic, ultimately addressing currently undruggable targets.